Neurobehavioral markers of positive valence systems in mothers with depression and young offspring

PROJECT SUMMARY
Depression is prevalent, debilitating, and costly, and derives from complex combinations of genetic and
environmental factors. Maternal depression is one of the most established risk factors of depression in
offspring, yet the genetic and environmental risk factors tied to intergenerational risk are complex and largely
unspecified. Dyadic research examining mother–child neural and behavioral processes is critically needed to
identify early pathways and mechanisms of increased depression risk. To this end, the current research
strategy suggests a neurobehavioral pathway of early childhood risk development such that depression in
mothers is characterized by dampened positive valence systems (PVS) neural activation, leading to decreased
engagement in co-experienced positive affect with young offspring, and resulting in dampened PVS neural
activation in the young children of mothers with depression. I will assess 125 mother−child (age=18months)
dyads. In the first laboratory visit, diagnostic interviews will assess mothers’ lifetime depression history. In the
second laboratory visit, dyads will complete a series of tasks to examine neural indicators of PVS activation
and mother−child co-experienced positive affect. Electroencephalogram (EEG) and event-related potential
(ERP) neural indicators, particularly frontal alpha asymmetry (FAA) and the late positive potential (LPP),
reliable measures of approach motivation and motivated attention, respectively, will be used to measure PVS
activation at the neural level for both mothers and young children. Co-experienced positive affect will be coded
via the Dyadic Interaction Coding System. This project will allow me to examine a potential neurobehavioral
pathway from depression in mothers to the development of increased depression risk in offspring. First, I will
examine the association between mothers’ depressive symptoms and neural PVS activation in the context of
interactions with offspring (Specific Aim 1). Then, I will examine the association between mothers’ depressive
symptoms, prenatally and postpartum, and observed co-experienced positive affect in mother–child
interactions and test the moderating role of individual differences in mothers’ neural PVS activation on this
association (Specific Aim 2). Lastly, I will examine the cumulative and unique effects of co-experienced positive
affect and mothers’ neural PVS function on children’s PVS function. These aims leverage a rigorous
multimethod research design to provide foundational insight on dyadic neurobehavioral mechanisms of
depression vulnerability, crucial for developing more targeted preventions for those at highest risk for
depression. In addition, my proposed training goals are to develop advanced skills through rigorous training in:
infant and early childhood mental health, dyadic behavioral paradigms and assessment of caregiver–child
interactions, dyadic and early childhood neurophysiological assessments, and advanced quantitative methods.

Public health relevance
PROJECT NARRATIVE Depression is prevalent, debilitating, and costly, and maternal depression is one of the most established risk factors of depression in offspring; however, the genetic and environmental risk factors tied to intergenerational risk are complex and largely unspecified. I will conduct a multimodal, dyadic research design to examine a potential neurobehavioral pathway from depression in mothers to the development of increased depression risk in young children. This study has relevance for identifying children at greatest risk for depression development according to neural indicators and proposing a behavioral target for intervention in mother−child processes in order to mitigate risk.